The role of structural variants and tandem repeats in substance abuse-related behavioral traits

Project Summary
Genome-wide association studies (GWAS) in model organisms such as mice and rats have identified
hundreds of genetic loci that are associated with addictive behaviors, but determining the causal genes remains
challenging. Single nucleotide polymorphisms (SNPs) may not adequately tag other classes of variants such as
structural and repetitive variants that have higher mutation rates. Thus, both panels of inbred strains and outbred
populations will fail to identify a subset of loci and causal alleles. We are proposing to address this serious
limitation by using cutting-edge methods to discover and genotype structural variants (SVs) and tandem repeats
(TRs). Because they are technically challenging to analyze, SVs and TRs have not yet been adequately surveyed
in rodents. However, there is already extensive evidence that SVs and TRs are prevalent in mice and rats, and
that they have important functional consequences. Our proposal brings together complementary expertise in
human genetics and bioinformatic analysis of SVs (Sebat) and repetitive variation (Gymrek) with established
leadership in elucidating the genetic basis of behavioral phenotypes in model organisms (Palmer). This study
will generate the first large-scale resource for analyzing the effects of complex variation on mouse and rat
phenotypes. We use this resource to examine gene expression and behavioral traits in inbred mice (BXD
recombinant inbred strains, the Hybrid Mouse Diversity Panel (HMDP), the Diversity Outbred (DO) mice, the
Hybrid Rat Diversity Panel (HRDP) and the Heterogeneous Stock (HS) outbred rats.
In Specific Aim 1 we will characterize SVs in inbred and outbred mice and rats by single-molecule
sequencing. In Specific Aim 2 we will genotype TR in inbred and outbred mice and rats. Finally, in Specific Aim
3 we will perform GWAS using SV and TR for gene expression and behavioral traits. We will determine the
phenotypic consequences of the SV and TR genotypes on gene expression and behavioral traits. We will impute
SVs and TRs into outbred mice and rats and then perform GWAS using the wealth of preexisting gene expression
and behavioral data that are available for the mouse and rat populations studied in this project. Completion of
this project will characterize the SV and TR landscape in mice and rats, elucidate their role in gene expression
and complex behavioral traits relevant to addiction, and create a community resource that will enhance numerous
ongoing mouse and rat genetic studies.
In this supplement request, we are extending on the studies funded by the parent grant to pursue a new
line of genetic analysis using the datasets produced by Aims 1 and 2. Specifically, we will calculate polygenic
risk scores (PRS) from GWAS summary statistics and determine if PRS modifies the effects of damaging large
effect SVs and TRs that are discovered by the parent grant.

Public health relevance
Project Narrative Drug abuse is complex disorder representing a serious public health challenge. Human genetics studies have identified a significant genetic contribution to the risk of developing drug abuse. Rodent genetic studies are vital to understanding the molecular genetic basis of drug abuse, but are hampered by an incomplete catalogue of potentially causative genetic variants. This supplement is to support a project for a postdoctoral fellow to explore two important but understudied sources of genetic variation: structural variants and tandem repeats.